Chemistry Human Food Product Testing

Project Summary / Abstract for State of Rhode Island PAR-20-105 Laboratory Flexible Funding Model (LFFM) (U19) Application. Discipline B: Chemistry, Track 2: Human Food Product Testing Project Summary/Abstract The purpose of this project is for the Rhode Island State Health Laboratories (RISHL) to engage in the systematic chemical analysis of human food products as part of ongoing surveillance sampling conducted in conjunction with our partners in the RIDOH Center for Food Protection (CFP). This surveillance program will result in the analysis of fruit juices for per- and polyfluoroalkyl substances (PFAS), with ultimate goal of helping advance knowledge on potential PFAS exposure from food. This research will assist in assessing the safety of human food from specific areas potentially affected by environmental contamination and hopefully help identify and prioritize future activities to reduce PFAS in human food.